Role of GSK3beta in diabetic kidney disease

ABSTRACT
Diabetic kidney disease (DKD) is the leading cause of end-stage renal disease with no definitive therapy yet
available. Emerging evidence suggests that defective insulin signaling in podocytes plays a key role in the
pathogenesis of DKD. In addition, the “final common molecular pathway” for glomerular degeneration contributes
to DKD, involving oxidative damage and stress-induced premature senescence. Glycogen synthase kinase
(GSK)3 is a critical transducer of insulin signaling, and also acts as a convergent point for myriad pathways
implicated in organ injury, repair, and regeneration. In renal glomeruli, GSK3β rather than the α isoform is
predominantly expressed and enriched in podocytes. Our latest studies demonstrated that GSK3β is hyperactive
in glomerular podocytes in clinical and experimental DKD, correlating with the severity and progression of DKD
and associated with accelerated podocyte senescence. However, the role of GSK3β in diabetic nephropathy
(DN) is extremely controversial based on very few studies solely relying on chemical inhibitors or activators with
specificity concerns. Preliminary data revealed that GSK3β catalyzes phosphorylation of p53 and p16INK4A,
pivotal mediators of senescence signaling in podocytes, and that GSK3β-regulated Keap1-independent Nrf2
antioxidant defense is a new actionable target for podocyte protection. Furthermore, GSK3β inhibition promotes
the expression and activity of retinoic acid (RA) receptor (RAR)α, a key transcription factor driving podocyte
differentiation and repair. Building logically on previous work, this project aims to conclusively define the exact
role of GSK3β in DN and test a novel hypothesis that targeting GSK3β in podocytes mimics or sensitizes insulin
signaling, reinforces Nrf2 antioxidant response, mitigates senescence, and synergizes with RARα signaling,
resulting in a beneficial effect in DN. Aim 1 will define the molecular mechanism underlying GSK3β regulation of
diabetic podocyte injury. GSK3β activity will be manipulated in podocytes exposed to the diabetic milieu and its
role in insulin signaling, Nrf2 response and accelerated podocyte senescence will be defined. Aim 2 will examine
the role of podocyte-specific GSK3β in DN. In mice with type 1 DN elicited by streptozotocin plus uninephrectomy,
or in db/db mice with type 2 DN, GSK3β activity will be promoted by GSK3β knockin or podocyte-specific GSK3β
hyperactivity, or inhibited by inducible conditional knockout (icKO) of GSK3β. The rescue efficacy of small
molecule inhibitors of GSK3β, including microdose lithium and tideglusib, on established DN will be further
evaluated. Aim 3 will test the synergistic effect of GSK3β inhibition plus RA on DN. Mice with icKO of GSK3β
and RARα in podocytes will be employed to determine if RARα contributes to GSK3β regulation of DN. The role
of GSK3β in regulating RARα activity will be defined using podocytes with differing GSK3β activity and validated
in GSK3βicKO mice with type 1 or 2 DN. The synergistic effect of RA plus GSK3β inhibitors on DN will be tested.
Collectively, these studies will provide a mechanistic view of the role of GSK3β in the pathogenesis of DN and
pave the way for trials of existing or novel medications with GSK3β inhibitory activities to treat DKD in men.

Public health relevance
PROJECT NARRATIVE Podocyte dysfunction, due to defective insulin signaling, oxidative stress or accelerated senescence, is a key determinant of progression of diabetic kidney disease, a severe disease that afflicts hundreds of millions of people worldwide and imposes a heavy burden on the treasury and health-care systems with no definitive treatment available yet. Our preliminary data demonstrated that glycogen synthase kinase (GSK)3β is hyperactive in glomerular podocytes in clinical and experimental diabetic kidney disease, correlating with the severity and progression of diabetic kidney injury. We now propose to continue to examine the role of GSK3β in the pathogenesis of diabetic kidney disease in hopes of developing innovative therapies to halt the progression of diabetic kidney disease by targeting GSK3β with the ultimate goal to improve kidney health.